Structural and Nucleotide Variation as Genomic Risks for Venous Thrombosis: TOPMED and INVENT Collaboration

ABSTRACT
Venous thromboembolism (VTE) is a heritable condition that includes deep vein thrombosis and pulmonary
embolism and is associated with marked morbidity and mortality. Genomic discovery can be a first step to
better understand human biology and it is well established that VTE has important genetic determinants.
Evidence supporting new associations has grown with advances in technology and sample size. Initial
exploration of rare and uncommon variation across the 3.1 billion nucleotides that constitute the human
genome using whole-genome sequencing (WGS) is providing interesting results for rare, potentially-damaging
single nucleotide variants (SNVs) in known VTE risk loci. Further, WGS can be used to fully characterizing
structural variants (SVs) genome-wide. Our preliminary data from the Atherosclerosis Risk in Communities
study using TOPMed WGS data reveals rare SV deletions in multiple genes known to be associated with risk
for VTE, including a deletion affecting a fibrinogen structural gene (FGB) that is associated with a 2-fold
increase in VTE risk. A systematic and agnostic genome-wide search for SVs associated with VTE has not
been conducted and will not be possible without dedicated resources, such as those proposed in this
application. This proposal is a collaboration between leadership within the TOPMed VTE Working Group, the
TOPMed Structural Variation Working Group, and the International Network Against Venous Thrombosis
(INVENT) Consortium. The following specific aims seek to uncover novel genomic variation (SVs and SNVs)
contributing to VTE risk using data from 17 studies that include 46,200 VTE cases and over 380,000 controls.
Aim 1: In TOPMed and INVENT participants, use novel methodology to generate high-quality and more
accurate SV calls than the SV calling algorithms currently available for both WGS and existing array data. The
new calls will be filtered, curated, and will be available for Aim 2. The SV call will also be shared within
TOPMed and applied by working groups to other cardiovascular, lung, and sleep phenotypes. Aim 2: Conduct
association analyses of SVs with VTE. Discovery: Using SV calls derived in Aim 1 to conduct gene-based,
segmental association analyses in up to 32,545 VTE cases and 170,000 controls. Validation and Replication:
SVs from statistically-significant gene-based association findings will be validated using quantitative PCR and
will be replicated in up to 13,655 VTE cases and 210,000 controls in populations/studies not used in the
discovery phase. Aim 3: Conduct association analyses of SNV genotypes with VTE. Discovery: Using SNV
data derived from WGS and WGS-imputed data (including insertions and deletions), conduct aggregate-variant
analyses of genes and regulatory regions for SNVs with MAF <0.05 for association with VTE in up to 32,454
cases and 170,000 controls using burden tests and the Sequence Kernel Association Test (SKAT). We also
propose analyses that combine SV and SNV data to analyze compound heterozygotes for loss-of-function
mutations and their association with VTE. Replication: Significant associations will be replicated as in Aim 2.

Public health relevance
NARRATIVE Venous thrombosis (blood clots in the legs and/or lungs) is a cardiovascular condition that is influenced by a person's DNA characteristics. Human DNA differs among people in many ways, and this project will look at 2 ways in which DNA differs among adults to see if these differences are associated with the risk of developing clots in the legs or lungs. We will first determine if the insertions of extra DNA material or deletions of DNA material are associated with risk; we will then determine if substitutions in DNA material are associated with risk.